Strategies to Innovate EmeRgENcy Care Clinical Trials Network (SIREN) - Clinical Coordinating Center (CCC)

The overall goal of the Strategies to Innovate Emergency Care Clinical Trials Network (SIREN) is to improve the outcome of patients suffering acute illness and injury by identifying effective treatments given in the earliest stages of care. Emergency conditions such as myocardial infarction, cardiac arrest, traumatic injury including brain and spinal cord injury, and seizures cause significant morbidity and mortality and exact a high cost in terms of human suffering and health care spending. Pre-clinical and translational research has demonstrated that there is a very narrow window of opportunity in which many novel treatments for emergency conditions are optimally effective, and that conducting research in the emergency setting presents unique pragmatic challenges to clinical investigators. Effective clinical trials in these conditions require a coordinated network of emergency physicians, surgeons, cardiologists, intensivists, neurologists and biostatisticians. This renewal application, in response to RFA-NS-22-014 describes the features, functions and coordination we will continue to provide as the Clinical Coordinating Center for the SIREN network. The key elements of this ongoing structure include an interdisciplinary team of investigators with specific expertise in the conduct of clinical trials of emergency interventions, a hub-and-spoke network design that acknowledges the importance of enrolling patients in the acute setting, and a long term network commitment to advancing the national research infrastructure as it relates to the interdisciplinary study of acute illness and injury. This project continues to create and maintain a coherent, collaborative, multidisciplinary emergency clinical trials community that is diverse and inclusive. The network will recruit, efficiently perform, and widely disseminate the most scientifically and clinically important trials necessary to advance the emergency care of patients with neurologic, cardiac, respiratory, hematologic and trauma emergencies. SIREN initiated 5 large, simple multicenter trials over the previous 5 year grant period, and will initiate at least 4 more in the next grant period. The network aims to transform the emergency research enterprise, by exploring innovations in clinical trial designs, by better and earlier engagement of patient stakeholders in trial planning, and by creative improvements in implementing and performing trials.

Public health relevance
The Strategies to Innovate Emergency Care Clinical Trials Network (SIREN) is an international multicenter clinical trials network. SIREN physicians and researchers study what treatments work best for patients with emergency conditions or injuries. Emergencies may involve heart, lung, or blood conditions, problems or injuries involving the brain or spinal cord, seizures, coma, or other traumatic injuries. The SIREN will study patients in ambulances and emergency departments, and the earliest stages of critical care, because many promising treatments may only work well if they are given very quickly after the onset of symptoms or injury.